Modeling of subcellular signaling crosstalk in failing myocytes

PROJECT SUMMARY/ABSTRACT.
Heart failure (HF) is a rapidly growing health problem characterized by alterations in myocyte ion currents, Ca
handling, contractile function and their neurohormonal regulation. Na dysregulation in HF is increasingly
appreciated as a major, yet understudied aspect of cardiac function, linked to abnormal contraction, metabolic
imbalance, and arrhythmia. By combining experimental and computational studies, this project aims to analyze
quantitatively the contribution of various Na fluxes to the Na derangements in HF, and to link mechanistically
intracellular Na dysregulation to mitochondrial function and cellular arrhythmias.
Quantitative systems models that integrate across interacting biochemical and biophysical functions are
essential for a mechanistic understanding of a complex clinical syndrome such HF, which involves multiple
interacting systems. Here, we will develop the first integrative rabbit ventricular modeling framework including
descriptions of intracellular Na and Ca handling, biochemically detailed models of Ca/calmodulin-dependent
protein kinase II (CaMKII) and β-adrenergic signaling pathways, pH regulation, and mitochondrial function. The
latter will be based on experimental data characterizing mitochondrial Ca handling and production of reactive
oxygen species (ROS) in rabbit ventricular myocytes. The comprehensive model will be validated against a
broad set of experimental data, and used to investigate how Na, Ca, CaMKII, ROS, and β-adrenergic signaling
pathways contribute to (1) ionic remodeling in HF, (2) arrhythmia generation at the cellular level, and (3)
metabolic imbalance. We will also test therapeutic approaches that target Na-related arrhythmias by specific
inhibition of late Na current, CaMKII or ROS.
Our study will provide enhanced mathematical models of these systems and substantially inform the
development of pharmacological strategies. Moreover, the proposed project will significantly contribute to the
personal and professional growth of the applicant. The first phase will provide an invaluable training
opportunity, which will enhance the applicant’s competitiveness for faculty positions. Indeed, the proposed
research plan will allow for acquisition of a broad interdisciplinary background in cardiac physio-pathology,
refinement of computational skills, and training in new experimental techniques (i.e., cell culture and
transfection, and confocal microscopy experiments). Completion of this training, under the supervision of an
established and highly multidisciplinary mentoring team, will allow the applicant to diversify research goals and
methods from those of his mentors, laying the groundwork for the development of future independent research
projects and proposals. Continuation of the support during the second phase of the project will ensure the kick-
off of the applicant’s independent academic career.

Public health relevance
PROJECT NARRATIVE. Dysregulation of intracellular sodium (Na) homeostasis is an important yet understudied aspect of heart failure- induced remodeling. By combining in vitro and in silico approaches, this project aims to assess quantitatively the contribution of various Na fluxes and interplay of various signaling pathways to the Na derangement, metabolic changes, and arrhythmia initiation in failing myocytes. Our findings will significantly advance our ability to understand cardiac function in health and disease, thereby informing therapeutics.